Identifying Patterns of Health Care Utilization among Physical Elder Abuse Victims Using Medicare Data and Legally Adjudicated Cases

PROJECT SUMMARY
The over-arching aim of this research is to: improve understanding of the patterns of health care utilization and
associated costs of physical elder abuse victims to improve early identification and intervention and to inform
policy. In our prior research, supported by an NIA GEMSSTAR and Beeson grant to PI Dr. Rosen, we
leveraged unique partnerships with prosecutors’ offices to comprehensively examine legal case files from more
than 200 victims in two large metropolitan areas, representing the largest retrospective series of legally
adjudicated physical elder abuse cases ever examined. For the proposed study, we plan to link these cases,
for which we have done extensive clinical analysis, to Medicare claims data. The Specific Aims of this proposal
are: (1) To use Medicare claims to describe rates and patterns of health care utilization of victims before and
after detection, with a focus on potentially missed opportunities by health professionals to identify abuse and
differences based on victim characteristics, (2) To compare rates and patterns of ED visits and hospitalizations
of physical elder abuse victims to control groups selected algorithmically from Medicare claims data, and (3) To
compare patterns of health care utilization other than EDs/hospitals between victims and controls. The
proposed research will provide important insight into the patterns of health care utilization for physical elder
abuse victims, focusing on whether missed opportunities exist and suggestive patterns emerge. We plan to
employ sophisticated machine learning approaches to increase our ability to identify patterns suggestive of
physical elder abuse exposure. This will inform strategies for identification and intervention by health care
providers, and knowledge gleaned will support the future development of a health informatics tool to identify
potential victims. Findings on associated costs will help define the scope and impact of physical elder abuse.
This innovative approach leverages existing data gathered with NIA support and extrapolates from successful
research approaches in child abuse and intimate partner violence while expanding on them. As no additional
subjects will be prospectively enrolled as part of this research, we avoid many of the ethical concerns typical in
elder mistreatment work. Our multi-disciplinary team of experts in elder abuse, child abuse and neglect,
intimate partner violence, and emergency medicine as well as specialists in statistics, health economics, and
computer science is uniquely able to conduct this research. Previously, we have done seminal work examining
health care usage and health-related outcomes of elder abuse victims by linking adult protective services and
police databases to health care data, which is highly relevant for this proposal. We also have deep experience
in using Medicare claims data and machine learning for research. The long-term goal of our research is to
leverage a better understanding of health care use by elder abuse victims to improve the ability of health care
providers to identify, intervene, and prevent victimization and to inform policy changes to help this vulnerable
population.

Public health relevance
PROJECT NARRATIVE Elder abuse can have serious health consequences, but little is known about the patterns of their health care utilization. We propose to comprehensively examine the health care utilization and associated costs from known physical elder abuse cases using Medicare claims data. Findings from this research will improve the ability of health care providers to identify, intervene, and prevent victimization and to inform policy changes to reduce costs and help this vulnerable population.